Plasma neurofilament light chain as a potential disease monitoring biomarker in Wolfram syndrome

Wolfram syndrome (OMIM #222300) is a rare autosomal recessive disorder, characterized most frequently by
childhood-onset insulin dependent diabetes, optic nerve atrophy, sensorineural hearing loss, and diabetes
insipidus. Symptoms appear in early childhood and increase over time, ultimately resulting in blindness,
deafness, ataxia and other significant neurologic symptoms by early adulthood. Longitudinal analyses have
demonstrated that specific clinical (e.g. visual acuity, color vision) and derived neuroimaging variables (e.g.
thalamic & ventral pons volumes) deteriorate over time. These measures are now being used in an ongoing
clinical efficacy trial (ClinicalTrials.gov Identifier: NCT03717909). However, they are also costly, time-
consuming and require specialized on-site equipment and expertise. In contrast, a biofluid-based measure of
neurodegeneration would be cheaper, more easily standardized and repeatable, and thus extremely useful for
ongoing and future clinical trials designed to slow or halt neurologic progression. Emerging biofluid markers of
neurodegeneration, neurofilament light chain (NfL) and glial fibrillary acidic protein (GFAP), appear sensitive
but non-specific in neurodegenerative diseases. NfL levels are greater in plasma of individuals with Wolfram
syndrome compared to controls while GFAP has not been studied in this disease. We need to understand if
NfL is elevated in Wolfram independent of potential confounders including diabetic status and age, whether its
levels change over time and whether these changes track the progression of neurologic symptoms. Clinical
validation of NfL, and possibly GFAP, measured in the same blood sample using the same assay, is an
important precursor to proposing the use of NfL and/or GFAP in intervention studies or conducting
neuropathological validation studies in animal models. This proposal is focused on these necessary next steps
and, if successful, will provide a strong platform for using NfL and/or GFAP to monitor neurodegeneration in
Wolfram syndrome.

Public health relevance
Project Narrative: Wolfram syndrome is a rare genetic disease with no approved treatments or cure that affects young children, causing diabetes, vision and hearing loss and brain degeneration, resulting in death in mid-adulthood. However, work in animal models of Wolfram syndrome is progressing rapidly towards the identification of viable interventions for this process. The goal of the current proposal is to determine if a novel blood- based marker of neurodegeneration is elevated in Wolfram syndrome patients and is useful in tracking disease progression.